How Centrioles Control Mammalian Development

Project summary/Abstract
Centrioles, the core of centrosomes, have multiple fundamental roles including generating cilia, organizing
the microtubule cytoskeleton, and facilitating mitosis. Inherited defects in centrioles can cause important human
congenital diseases, including congenital heart defects and ciliopathies. Despite their importance to
development and disease, the molecular and cell biological mechanisms through which centrioles participate in
mammalian development remain poorly understood.
We have been investigating how centrioles function in mouse embryonic development. Remarkably,
disruption of different parts of the centriole affect different development events. For example, the distal centriole
component CEP97 is critical for cardiac septation, but dispensable for many other centriole- and cilia-dependent
events. In contrast, the proximal centriole component ALMS1 is critical for maintaining brain cilia, but
dispensable for heart development.
Interestingly, we found that removing centrioles altogether affects different cell types differently. For
example, removing centrioles from the intestinal epithelium does not affect its development, but removing
centrioles from the lung epithelium blocks lung branching. Thus, not only do different parts of the centriole have
different functions in development, but different cell types use centrioles in different ways.
Our proposal builds on this work by investigating how centrioles direct mammalian development, with a
focus on heart, lung and inner ear development. Using tools like centrosome affinity capture mass spectrometry
(CAPture-MS) and pan-Expansion Microscopy of tissue (pan-ExM-t) to mitigate barriers in studying centrioles,
we examine how centriole defects lead to human disorders such as congenital heart disease and Alström
syndrome.
In Aim 1, we focus on how CEP97 promotes ciliogenesis in the second heart field, essential for cardiac
septation. We investigate how CEP97 controls centriole length to enable ciliogenesis. In Aim 2, we explore how
removing centrioles activates the mitotic surveillance pathway (MSP) to disrupt lung branching. We seek to
understand how some lung progenitors apoptose in response to MSP activation while others do not. In Aim 3,
we study how a proximal centriolar protein, ALMS1, supports ciliogenesis and transition zone assembly on the
other end of the centriole.
Thus, in addition to illuminating how centrioles function in development and disease, this project
investigates how centrioles are constructed, how centrioles mature to generate cilia, how centrioles promote
cell survival, and how cells ensure that they have neither too few nor too many centrioles.

Public health relevance
Project Narrative We are investigating how the centriole, a key organizer of the cellular cytoskeleton, functions in embryonic development and how inherited defects in the centriole can cause birth defects. This project is especially focused on understanding how different centriole defects cause problems in the development of the heart, the lungs and the inner ear. Our work will illuminate how different parts of the centriole function differently, and how different cell types use centrioles in different ways, relevant to human congenital diseases.